Light Activation of Retinal Insulin Receptor Signaling

Project Summary/Abstract Studies from our laboratory over the past decade have found the existence of a novel light-dependent insulin receptor (IR) signaling pathway in rod photoreceptors. We have discovered that IR activation is functionally important for rod survival, since its deletion in rods resulted in the loss of neuroprotective survival signaling. This novel pathway uses growth factor receptor bound protein (Grb14), an upstream regulator of IR, and requires photobleaching of rhodopsin for membrane targeting. Grb14 protects light-dependent IR activation in rod photoreceptors against dephosphorylation by PTP1B. Light-activated IR is subsequently associated with phosphoinositide 3-kinase (PI3K), a cell survival factor, and thus regulates the downstream survival pathway. These studies suggest that rhodopsin photoexcitation may trigger signaling events alternative to the classical transducin activation. Recently, it was suggested that the IR signaling pathway is important for cone photoreceptor survival in retinitis pigmentosa (RP) models since systemic administration of insulin delays the death of cone photoreceptors. We found that insulin-like growth factor-1 receptor (IGF-1R) also activates PI3K and Akt survival pathway in rods under light stress. It is our hypothesis that IR/IGF-1R signaling pathways are important for survival and maintenance of rod and cone photoreceptor structure and function. The long-term goal of our project is to gain a greater understanding of the intracellular signaling pathways that provide neuroprotection to both rod and cone photoreceptor cells. The specific objective is to investigate the role of IR and IGF-1R in the regulation of photoreceptor structure and function. To this end, we will determine the mechanism by which Grb14 activates the IR and determine the functional roles of IR and IGF-1R in both rod and cone photoreceptor cells. We will utilize a combination of genetic, molecular, and biochemical approaches to address our specific aims. Results from these studies will lead to a better understanding the roles of IR and IGF-1R signaling in photoreceptor structure, function and survival.

Public health relevance
Project Narrative Insulin receptors (IR) and insulin signaling proteins are widely distributed throughout the central nervous system (CNS). Disregulation of IR signaling in the CNS has been linked to the pathogenesis of neurodegenerative disorders such as Alzheimer's and Parkinson's disease. In retinal rods, IR signaling is neuroprotective, and recently it was shown that insulin delays the death of cone photoreceptor in retinitis pigmentosa animal models. Besides IR, insulin-like growth factor-1 receptors (IGF-1R) are also expressed in both rods and cones; however, their functional role has not been elucidated. Our studies suggest that protein tyrosine phosphatase 1B (PTP1B) negatively regulated neuroprotective survival signaling of the IR. Our studies also suggest that a defect in the photobleaching of rhodopsin and mutations in rhodopsin gene enhances the activity of PTP1B and this activated activity could down regulate the IR survival signaling. Controlling the PTP1B activity and activating the IR signaling would provide sustained neuroprotection to both rods and cones. Our new and innovative approaches to target PTP1B will facilitate future translational application of our work, with the goal of applying our findings to the clinical care of human retinal degenerations. Studies proposed in this grant application would help to understand the functional roles of IR and IGF-1R in photoreceptor structure, function and survival.